The molecular pathophysiology of the congenital dyserythropoietic anemias

Project Summary
Anemia due to defects in erythropoiesis (red blood cell production) is a major source of mortality and morbidity
worldwide. The Congenital Dyserythropoietic Anemias (CDAs) are a group of disorders of terminal erythroid
maturation defects characterized by ineffective erythropoiesis and distinctive bone marrow findings. Multiple
CDA subtypes exist; CDAII is the most common variant, followed by CDAI. Despite the identification of the
genetic defects underlying CDAI and CDAII, the pathophysiology of these disorders remains largely unknown.
CDAII is an autosomal recessive disease resulting from mutations in SEC23B, encoding a core component of
coat protein complex-2 (COPII) vesicles, which transport secretory proteins from the Endoplasmic reticulum to
the Golgi apparatus. We generated a SEC23B deficient human erythroid HUDEP2 cell line. SEC23B deficient
HUDEP2 cells survive and expand normally when maintained as proerythroblasts in expansion media;
however, upon culturing the cells in differentiation media, these cells exhibit reduced viability and impaired
differentiation, as seen in human CDAII. Using this cell line, in preliminary results, we performed a genome-
scale CRISPR knock-out screen to identify genes that, when deleted, rescue the CDAII differentiation defect.
LRF and miR-451 were 2 of the top hits of the CRISPR screen, which validated in additional preliminary
experiments. In aim 1 of this proposal, we propose to define the mechanism by which deletion of LRF and miR-
451 rescue the CDAII erythroid defect. Furthermore, we recently showed through studies in mice and human
cells that SEC23B overlaps in function with its closely related paralog, SEC23A. We generated a reporter
human erythroid HUDEP2 cell line that expresses eGFP-tagged SEC23A from the endogenous SEC23A locus.
Using CRISPR activation (CRISPRa), we found that increasing the SEC23A level by as little as 30% is
sufficient to ameliorate the CDAII defect. In preliminary findings, we tested ~5,000 compounds from the drug
repurposing library for their ability to increase SEC23A. The top hits form this screen included RN1 (LSD1
inhibitor) and decitabine (DNMT1 inhibitor), both of which showed in validation experiments i) >10-fold
increased SEC23A expression in erythroid cells differentiated from CD34 hematopoietic stem cells in vitro, and
ii) absence of erythroid differentiation defects at doses sufficient to therapeutically increase SEC23A. In aim 2
of this proposal, we propose to define the roles of RN1 and decitabine in rescuing the CDAII erythroid defect.
Finally, we utilized our newly established inducible Gata1-Cre recombinase allele to delete Cdan1 in the adult
erythroid compartment, which allowed us to generate the most accurate CDAI model in adult mice, to date.
Using this CDAI murine model, we propose several experiments in aim 3 to study the role of CODANIN1 in
erythropoiesis. These studies have important implications for understanding the pathophysiology of the CDAs
and may lay the foundation for the development of novel therapies for these disorders.

Public health relevance
Project Narrative The congenital dyserythropoietic anemias (CDAs) are a group of disorders characterized by distinctive bone marrow findings and ineffective erythropoiesis (red blood cell production), for which the molecular pathogenesis remains largely unknown. Based on strong preliminary results, this project aims to define the roles of novel compounds and molecular pathways in ameliorating the erythroid differentiation defect observed in CDAII, and to study the molecular pathogenesis of CDAI. Our studies have important implications for understanding the pathophysiology of the CDAs, which is expected to be relevant to other disorders of defective red blood cell production that are a major source of morbidity and mortality worldwide.